Transcription-dependent and -independent signaling of RSK2 in cancer metastasis

Metastasis is a complex biological process, which involves multiple signaling pathways. Therefore, a single agent
is often insufficient and combination therapy is vitally important in the successful treatment of metastatic cancer.
We reported that p90 ribosomal S6 kinase 2 (RSK2) promotes metastasis by activating multiple downstream
substrates. In addition, we recently identified that glutamate dehydrogenase 1 (GDH1), a critical enzyme in the
glutaminolysis pathway, provides anti-anoikis signals by activating CamKK2 and its downstream AMPK to
regulate energy production, protecting cells from anoikis, and promoting metastasis in lung cancer. The effect of
GDH1 is evident in LKB1-deficient cancer, where AMPK activation predominantly depends on CamKK2. This
suggests that RSK2 and GDH1 are promising anti-metastasis targets. Indeed, targeting RSK2 or GDH1 by fmk
(identified by our collaborator Jack Taunton at UCSF) or R162 (identified by our group) attenuated metastasis.
We recently found that genetic or pharmacological inhibition of these two distinct signaling axes results in
synergistic attenuation of cell invasion, migration, and anoikis resistance in LKB1-deficient lung cancer.
Biological and metabolic studies revealed that the combined therapy further attenuates CREB activation.
Intriguingly, GDH1 knockdown resulted in decreased activity of CamK4, another upstream kinase of CREB,
suggesting that combined targeting of RSK2 and GDH1 may further attenuate CREB activity by inhibiting RSK2
and GDH1-CamKK2-CamK4 signaling involved CREB phosphorylation. In addition, combined targeting of RSK2
and GDH1 synergistically induced anoikis in LKB1 wild-type (wt) expressing cells and RSK2 directly
phosphorylated LKB1, leading to AMPK activation. These data suggest that RSK2 may signal through LKB1 and
AMPK to contribute to anoikis resistance in LKB1 wt cells.
Thus, we hypothesize that RSK2 and GDH1 coordinately regulates AMPK and CREB in transcription-
dependent and -independent manners to provide pro-metastatic potential in cancer cells. Thus, targeting both
cellular and metabolic signaling by combination of RSK2 and GDH1 inhibitors is a promising anti-metastasis
therapeutic strategy. We will use lung cancer with LKB1 or LKB1 null as a research platform. Three specific aims
are proposed: (1) To demonstrate whether RSK2 and GDH1 coordinately provides anti-anoikis protection to
cancer cells by activating AMPK through LKB1 and CamKK2, respectively; (2) To determine whether RSK2 and
GDH1 together mediates migratory and pro-invasive signals by activating CREB and CREB transcription targets;
(3) To validate whether RSK2 and GDH1 signaling correlates with metastatic potential in patient tumors and
evaluate the therapeutic efficacy of targeting RSK2 and GDH1 in combination in treatment of metastatic cancers.

Public health relevance
Metastasis is the leading cause of death in human patients, but the mechanisms remain unclear. We found that p90 ribosomal S6 kinase 2 (RSK2) and glutamate dehydrogenase 1 (GDH1) promote anti-anoikis protection, invasion, migration, and tumor metastasis in human cancers. In this proposal, we will examine by which RSK2 and GDH1 coordinatively promote tumor metastasis by providing cellular and metabolic advantages to cancer cells and validate therapeutic efficacy of targeting RSK2 signaling pathways in combination with GDH1 inhibitors as a novel anti-metastasis therapy.